PULSE DeveloPing a pragmatic gUide to impLementing social riSk assistancE

PROJECT SUMMARY
This supplement is a collaborative effort across four ISC3 Centers: BRIDGE-C2, Harvard ISCCCE, University
of Washington OPTICC, and Washington University (WU)-ISC3. Addressing patients’ social needs is a critical
part of enabling patients to access evidence-based cancer screening and prevention interventions, a focus of
the WU-ISC3 Center. Well-documented challenges in addressing social needs include determining how best to
maintain up-to-date information about available service agencies to which persons with social needs may be
referred, and developing and adopting optimal workflows for doing so. Social service resource locators
(SSRLs) that identify currently available resources take varying forms ranging from a social worker maintaining
a hard-copy binder of resources to an informatics platform integrated into the electronic health record and
designed to enable bidirectional communication with local organizations about referred patients’ receipt of
services (also called community resource referral platforms). Building on the findings from the Phase I
supplement, we propose to: (1) develop a pragmatic, applied guidebook (the Guide) for clinics seeking to
implement or expand efforts to address patient-reported social risks using Assistance strategies; (2) use rapid-
cycle testing to identify best practices for implementing the Guide; and (3) iterate and disseminate the refined
Guide. WU-ISC3 will test the guide in Missouri Highlands Health Care, a Federally Qualified Health Center in
rural southern Missouri, who face some of the most difficult implementation challenges as they primarily serve
patients with high social needs and are located in an outer context with fewer resources than urban areas.

Public health relevance
PROJECT NARRATIVE This supplement is a collaborative effort across four ISC3 Centers: BRIDGE-C2, Harvard ISCCCE, University of Washington OPTICC, and Washington University (WU)-ISC3. We propose to: (1) develop a pragmatic, applied guidebook (the Guide) for clinics seeking to implement or expand efforts to address patient-reported social risks using Assistance strategies; (2) use rapid-cycle testing to identify best practices for implementing the Guide; and (3) iterate and disseminate the refined Guide. This supplement will allow our team to collect the data needed to inform and align the research of our WU-ISC3 Center Parent grant as social risks are key influencers of health inequality and contribute to health disparities between populations and communities.